Developing robust and scalable genomics tools and databases to analyze immune receptor repertoires across broad populations

Abstract
The recent advances in high-throughput sequencing technologies enable cost-effective characterization of the immune system and provide novel opportunities to study adaptive immune receptor repertoire (AIRR) at the population scale. In particular, AIRR analysis provides essential insight into the complexity of the immune system across a large variety of human diseases, including infectious diseases, cancer, autoimmune conditions, and neurodegenerative diseases. A commonly used assay-based approach (i.e. AIRR-Seq) provides a detailed view of the adaptive immune system by leveraging the deep sequencing of amplified DNA or RNA from the variable region of the T and B cell receptors (TCR and BCR) loci. However, the limited number of samples probed by the AIRR-Seq approach restricts the ability to detect novel population-specific V(D)J gene alleles across genetically varied populations. Non-targeted next-generation sequencing (NGS) (e.g. WGS) promises to fill the existing data gap by providing hundreds of thousands of NGS datasets across various population groups. However, reliable and scalable bioinformatics algorithms have yet to be developed to utilize non-targeted NGS technologies to assemble novel population-specific alleles that would support effect-size heterogeneity across populations. There's a lack of comprehensive population-specific allelic immunogenomics reference databases. The current state-of-the-art databases were built on the genetic architecture based on selected individuals from small cohorts and thus fail to capture allelic variation across large populations. We propose to utilize a data science approach for studying the variation of the human adaptive immune system at a truly global scale, improving studies of immunological health and diseases, and reducing health outcome gaps. In this study, we will develop robust and scalable bioinformatics tools and databases able to leverage the largest datasets covering individuals across multiple cohorts composed of over half a million NGS samples spanning the AIRR-Seq, RNA-Seq, and WGS technologies. We will perform rigorous benchmarking of the developed bioinformatics methods based on both simulated and real data to demonstrate the feasibility of using NGS-based approaches to assemble novel V(D)J alleles. The availability of large and genetically varied sets of samples will allow us to discover novel population-specific V(D)J alleles, which will enrich existing immunogenomics databases with population-specific immune alleles. To promote the dissemination of the obtained results, the novel alleles and assembled receptor sequences will be shared as an easy-to-use database with a rich set of functionalities.

Public health relevance
Project Narrative The recent advances in high-throughput sequencing technologies enable cost-effective characterization of the immune system and provide novel opportunities to study adaptive immune receptor repertoire (AIRR) at the population scale. In this study, we will develop robust and scalable bioinformatics tools and databases to leverage the largest dataset covering individuals across multiple population groups composed of over half a million NGS samples. The availability of large and genetically varied sets of samples will allow us to discover novel population- specific immune alleles and clonotypes and will enhance our understanding of human adaptive immune responses across heterogeneous populations.